HCMV US28 Signal Transduction by Betaarrestin proteins

DESCRIPTION (provided by applicant): Human Cytomegalovirus (HCMV) infection is a leading cause of viral associated congenital birth defects and has proven to be a significant public health problem in organ transplant recipients as well as in individuals with AIDS. Accumulating evidence indicates that there may be a relationship between HCMV and the development of vascular disease. The interplay between HCMV and the immune system is a critical factor in the events leading to initiation of disease. Interestingly, HCMV encodes several genes that appear to modulate immune system function. One of these genes, termed US28, is homologous to the mammalian chemokine G-protein coupled receptors (GPCRs). While progress has recently been made in the identification of signaling pathways downstream of US28, very little is known regarding the molecular details proximal to US28 that contribute to the activation of signaling pathways. The objective of this proposal is to identify specific receptor properties and molecular events proximal to US28 that are critical for activation of known signal transduction pathways. We hypothesize that a detailed study of the molecular interactions of betaarrestin proteins with US28 will generate novel insights into the regulation of US28 signaling. The betaarrestins were originally identified in the context of termination of "traditional" G-protein signaling to effectors such as adenylyl cyclases and phospholipases. This termination process, also known as desensitization, involves receptor phosphorylation by GRKs and binding of betarrestin proteins. It is now clear that the betaarrestins simultaneously function as adapter/scaffold molecules to recruit signaling proteins to receptors in order to activate additional "non-traditional" signaling pathways. We have identified a US28 mutant that is unable to interact with betaarrestin and have generated a significant amount of preliminary data regarding signaling from this mutant. We propose to analyze the involvement of betaarrestin proteins in US28 signaling in order to gain a greater understanding of the proximal events leading to activation of US28 signaling pathways. To accomplish this goal, we propose three specific aims. First, we will characterize "traditional" signaling from this US28 mutant in the context of HCMV infection and will analyze how this mutant affects the ability of US28 to stimulate smooth muscle cell migration. Second, we will analyze "non-traditional" signaling pathways from US28 potentially mediated by betaarrestin recruitment to the US28 carboxy terminal regulatory domain. Third, we will analyze US28 signaling in cells deficient for betaarrestin expression in order to specifically define the involvement of betaarrestins. Our preliminary data indicate that US28 engages βarrestin proteins suggesting that we will be able to make rapid progress toward our goal of defining the role of these important regulatory proteins in US28 signaling. These studies will identify mechanisms regulating US28 mediated signal transduction and will enhance our understanding of how US28 participates in pathogenesis and initiation of HCMV disease.